Flexible Hybrid Cloud Infrastructure for Seamless Management of HuBMAP Resources

Project Summary not required for PA‐18‐591 Request for Supplement to Existing NIH Grants and Cooperative Agreements

Public health relevance
Project Narrative not required for PA‐18‐591 Request for Supplement to Existing NIH Grants and Cooperative Agreements